Ethically-focused multimodal AI models for precision treatments of breast cancer

Abstract
Breast cancer is the most commonly diagnosed cancer among women worldwide. Patients diagnosed with
breast cancer face the important question of what therapeutic regimens to choose, and they are eager to
know the effects of potentially applied treatments. While treatment decisions have become more refined
over time, they are not personalized and as such patients may still be over or undertreated. There is a
paramount need to integrate the multi-scale, multi-modal, and multi-timepoint patient data and to build
the capacity of systematically and accurately assessing a patient’s individual data to guide precision
treatments of breast cancer. The complexity of multi-modal datasets poses challenges for physicians to
interpret and integrate information, where artificial intelligence (AI) and data science are capable of
extracting, aggregating, and inferring predictive insights. The goal of this study is to develop ethically
designed AI prediction models using multi-modal data (clinical variables, medical images, and genomics
assays, from individual, macro-scale, to micro-scale and longitudinal) to assess treatment efficacy of
breast cancer and guide precision treatment decision-making. We propose establishing a multi-center
collaboration network (University of Pittsburgh, Duke University, and MD Anderson Cancer Center) to
curate diverse patient data for the AI model development and evaluation. We have assembled an
experienced multi-disciplinary team with data scientists, oncologists, radiologists, geneticists, surgeons,
pathologists, biologists, and biostatisticians. We propose to study two specific aims to demonstrate the
concept by year 2 through establishing the team and collaboration network, delivering AI models,
contributing new AI techniques, and crafting plans for continued work.

Public health relevance
Public Health Relevance Statement: Breast cancer is the most diagnosed cancer among women worldwide, and breast cancer patients face the important question of what treatments to choose. The goal of this project is to develop ethically designed artificial intelligence (AI) tools that utilize multiple data modalities (imaging, clinical, pathology, and genomics) to predict the efficacy of breast cancer treatments and guide precision treatment decision making. The AI tools will help tailor individualized treatments to achieve better outcomes, and minimize toxicities, harms, and side effects caused by over-treatments.